Multi-component Lifestyle Intervention to Improve Outcomes in Black Adults with Chronic Kidney Disease

Project Summary/Abstract:
Excess cardiovascular disease (CVD) mortality among Black Americans with chronic kidney disease (CKD) is
a significant US public health disparity. Compared to their White counterparts, Black Americans develop kidney
disease earlier in life, are 3.5-fold more likely to develop kidney failure, and are 1.5-fold more likely to die
prematurely from CVD. Uncontrolled hypertension, which is also more prevalent and more severe in Black
adults with CKD compared to Whites, is a major risk determinant of CKD progression and CVD mortality.
Therefore, improving hypertension control rates in Black adults with CKD could have a profound positive
impact on an important minority health challenge. Multi-component lifestyle modification, including healthful
dietary changes, increased physical activity and weight management, is proven to lower BP in adults with
normal kidney function. However, the impact of multi-component lifestyle modification on BP in adults with
CKD is yet to be determined. The quality of evidence from the few existing randomized controlled lifestyle
intervention trials involving patients with CKD is poor due to a lack of power to detect changes in BP and
kidney function. Moreover, Black adults and patients with advanced CKD have been historically under-
represented in such trials despite each sharing an excess burden of poor kidney and CVD outcomes. It cannot
be assumed that lifestyle modification will effectively lower BP in patients with advanced CKD considering they
have a pathophysiology that causes their BP to be more severely elevated and less responsive to standard
anti-hypertensive medications than patients with normal kidney function. Culturally-adapted strategies may
also be necessary to improve hypertension and kidney health disparities among Black adults. The goal of this
study is to conduct an adequately powered randomized controlled trial to determine whether a multi-
component lifestyle intervention improves BP in Black adults with advanced CKD. We will randomize 152
adults with an estimated glomerular filtration rate of 15-44 ml/min/1.73m2 to either: 1) a 4-month lifestyle
intervention involving weekly culturally-adapted, low-sodium DASH diet counseling, thrice-weekly supervised
exercise, and weight management delivered in a cardiac rehabilitation setting, or 2) a usual care control
condition involving a one-time 30-minute low sodium diet consultation plus an exercise prescription to self-
implement without study support. Our primary outcome will be change in clinic systolic BP (SBP) from baseline
at 4 months. Our secondary outcomes will be changes at 4 months in 24-hour ambulatory SBP, DASH diet
score, urinary sodium-to-potassium ratio, peak oxygen consumption, and 24-hour urine albumin excretion. We
will also assess sustainability of the intervention effect 12 months post-randomization and explore the effect of
individual level and engagement level factors on variability in response at 4 months and 12 months. Findings
from our study will have important implications for expanding BP management options for an understudied
racial subgroup and a CKD sub-population using a strategy that is feasible for future implementation.

Public health relevance
Project Narrative High blood pressure (BP) control rates are low among Black Americans with advanced chronic kidney disease (CKD), which accelerates their development of kidney failure and causes them to die prematurely from cardiovascular disease (CVD). The purpose of the proposed study is to test the effectiveness of a culturally- adapted lifestyle intervention delivered in center-based cardiac rehabilitation setting to improve BP in Black adults with advanced CKD. This study will provide high quality evidence concerning the utility of lifestyle interventions to improve health behaviors and risk factors for CKD progression in a patient population that is understudied and underrepresented in clinical research.